Decoupling acute toxicities and antitumor efficacy in adoptive cell therapy

Project Summary
Adoptive cell therapy (ACT) with chimeric antigen receptor (CAR) T cells has demonstrated impressive
response rates in B cell malignancies, but ACT has not mediated sustained responses in solid tumors. CD19
CAR T cell therapy has reached up to 80% response rate in the clinic; however, the main side effects are
cytokine release syndrome (CRS) and immune effector cell-associated neurotoxicity syndrome (ICANS), which
occur in 37–83% and about 25-35% of patients, respectively. Furthermore, one of the major obstacles in ACT
is the heterogeneity of targeted antigens and relapse due to antigen escape. Recently, we screened a cohort
of 16 FDA-approved anti-inflammatory drugs and identified clofazimine (CLF) as the top candidate for its
desired bifunctional effect for anti-CRS/ICANS and anti-antigen escape roles. Aim 1 will determine the role of
CLF in reducing macrophage-derived ROS to curtail CRS/ICANS. Aim 2 will determine the role of CLF in
driving dsRNA/dsDNA signals in macrophages for the eradication of tumors. We expect this study to
demonstrate the ability of CLF in potentiating the anti-antigen escape capacity in ACT, curbing intractable
CRS, and may also fill a desperate clinical need to improve the dismal patient survival with ICANS. This
strategy of repurposing the clinically approved CLF may hold great promise to overcome a critical obstacle in
realizing the full potential of ACT with CAR-T cells. This translationally relevant work could then lay the
foundation for future clinical trials.

Public health relevance
Project Narrative In this project we will determine the roles of specialized white blood cells, called chimeric antigen receptor (CAR) T cells, in promoting an immune response against tumors and reduction of toxicity in mice when combined with an FDA-approved anti-inflammatory drug and determining their potential for use in cancer adoptive cell immunotherapy. We hypothesize that transfer of these tumor-killing CAR T cells will eradicate established tumors and prevent recurrence in vivo in both mouse and human tumor models, due to their ability to 1) directly kill the tumor cells; 2) reprogram macrophage to facilitate host antitumor immune responses, and 3) reprogram macrophage to reduce toxicities.